Treatment monitoring in early and locally advanced breast cancer using circulating tumor DNA analysis

PROJECT SUMMARY
Patients with early and locally advanced breast cancer (ELABC) are treated with a combination of pre-
operative (neoadjuvant) therapy, surgical resection and post-operative (adjuvant) therapy. In recent years,
overall survival for ELABC has improved to ~90% at 5 years. However, to achieve this goal, patients are often
over-treated due to lack of effective biomarkers. For example, a majority of patients who receive adjuvant
therapy are already cured after surgery and derive no further benefit. Similarly, almost a third of patients
treated with neoadjuvant therapy are found to have pathological Complete Response upon surgery (no
evidence of tumor upon histopathology), suggesting that the surgery could have been safely omitted. An
effective biomarker for minimal residual disease (MRD) can help personalize treatment plans and reduce over-
treatment, while preserving outcomes in patients with breast cancer.
Recent literature shows post-operative detection of circulating tumor DNA (ctDNA) can identify recurrence,
months before it is recognized on imaging. However, due to lack of sensitivity of current methods and limited
blood sample volumes, ctDNA signal often drops below limit of detection. Current approaches for ctDNA
analysis do not have adequate sensitivity to detect residual disease during and after completion of treatment.
To address this gap, we have developed TARgeted DIgital Sequencing (TARDIS), an approach for
multiplexed analysis of several patient-specific mutations in ctDNA. In this application, we propose to first
analytically validate TARDIS for ctDNA detection and then clinically validate this approach as a biomarker for
treatment monitoring and residual disease detection in early and locally advanced breast cancer. In the UH2
analytical validation phase, we will assess analytical sensitivity, specificity, accuracy, precision and
reproducibility of TARDIS using reference material, tumor cell line dilutions and plasma samples from patients
with breast cancer. In the UH3 clinical validation phase, we will measure baseline ctDNA detection rates in
patients with early and locally advanced breast cancer, evaluate whether ctDNA levels after neoadjuvant
treatment are predictive of pathological Complete Response and evaluate the prognostic value of ctDNA
detection after surgical resection for disease-free survival.
Our goal is to enable greater precision in treatment of patients with early and locally advanced breast cancer.
Once validated, ctDNA analysis and monitoring will complement existing diagnostic approaches such as
imaging and histopathology to help optimize management of patients with early and locally advanced breast
cancer.

Public health relevance
PROJECT NARRATIVE Outcomes for early and locally advanced breast cancer have improved recently but to achieve these, many patients with breast cancer are often over-treated. Current tests don't have adequate sensitivity to identify patients with microscopic disease who need prolonged treatments and spare others who have been already cured with less aggressive therapy. We have developed a blood test approach to address this gap and in this project, we will evaluate its performance to detect mutated cancer DNA shed in blood samples during and after treatment.